Bispecific antibodies in multiple myeloma: understanding therapy resistance through imaging

Summary
Bispecific T-cell engager antibodies (BiTEAs) targeting the B cell maturation antigen (BCMA) and G protein
coupled receptor class C group 5 member D (GPRC5D) have shown promising efficacy in the treatment of
relapsed and refractory multiple myeloma (MM). These treatments redirect the patient’s own T cells to elicit an
anti-tumor response. Approximately 35% of patients do not respond to these therapies despite the presence of
the target antigen on the tumors and the exact mechanism of this resistance is not well understood. Additionally,
almost all patients relapse eventually and patients with extramedullary disease have a much shorter duration of
response. We therefore need tools to better understand T cell engagement and trafficking in the context of these
therapies and strategies to improve efficacy particularly in patients with extramedullary disease. Unlike invasive
biopsies, non-invasive imaging can elucidate the role of BiTEAs in engaging endogenous T-cells towards the
tumor cells on the whole-body level. In this study we aim to develop a novel T-cell imaging paradigm that will
provide real-time information on the endogenous T-cell trafficking, tumor targeting, and persistence in patients
with MM under BiTEA treatment. We hypothesize that T-cell specific anti-CD8 and anti-CD4 PET agents will
allow for continuous monitoring and prediction of the efficacy of BiTEA therapies supported by local radiation for
medullary and extramedullary disease in MM. Our results, we predict, will provide preclinical support and
justification to move toward clinical application in patients with MM and other cancers undergoing immunotherapy
with BiTEAs.

Public health relevance
Narrative By redirecting the patient’s own T-cells to elicit an anti-tumor response, bispecific T-cell engager antibodies (BiTEAs) have shown promising efficacy in the treatment of relapsed and refractory multiple myeloma (MM). However, as all patients eventually relapse, and patients with extramedullary disease have a much shorter duration of response, we need tools to better understand T cell engagement and trafficking in the context of these therapies. In this study, we aim to develop a novel T-cell imaging paradigm that will provide real-time information on the endogenous T-cell trafficking, tumor targeting, and persistence in patients with MM under BiTEA treatment.